Genome-wide Analysis and Enrichment of Chimeric DNA Fragments in Plasma for Early Detection of Cancer

PROJECT SUMMARY
Early detection of cancer leads to improved prognosis and relative survival. Cell-free DNA (cfDNA) has been
used to detect cancer earlier in previous studies. However, without tumor tissue available, these methods rely
on screening for commonly mutated loci in cancer-associated genes, such as TP53, or examining genome-
wide alterations in methylation or fragmentation. These approaches have limitations. Examining single
nucleotide variants in cancer-associated genes can have lower sensitivity if the tumor does not harbor a
hotspot mutation. For genome-wide alterations, the shifts noted in cfDNA fragmentation or methylation are not
cancer-specific and generally a result of cellular disruption. Thus, there is a need for a signature that is both
specific to cancer and sensitive enough to be assayed from cfDNA. Structural variants (SVs) are a potential
biomarker for early detection. SVs are the result of errors in DNA damage repair wherein there is an aberrant
joining of two distant genomic loci, which results in a derivative chimeric DNA fragment with an identifiable
breakpoint. Importantly, SVs occur in most cancer types and are less likely to be PCR-derived false positives
compared to single nucleotide variants. However, tailoring a cfDNA assay to SVs is not without challenges.
Identifying specific SVs with high confidence and precision is informatically difficult and requires high
sequencing depth (>50x). Here, we hypothesize that genome-wide locus-agnostic detection and quantification
of chimeric DNA molecules can be utilized as a multi-cancer biomarker for early detection. Chimeric molecules
(CMs) contain the breakpoint of the SV they are derived from. This project seeks to develop laboratory and
computational methods to detect CMs in plasma DNA, identify sources of technical noise that affect CM
detection, and evaluate CMs as quantitative cancer biomarker (Aim 1). Furthermore, we plan to develop
laboratory methods to enrich rare chimeric molecules from abundant non-chimeric DNA fragments to improve
sensitivity for cancer detection and reduce associated sequencing costs (Aim 2). Together, these aims will lead
to the development of an assay for screening and earlier detection across multiple cancer types. This will be
accomplished in conjunction with the University of Wisconsin–Madison’s institutional support and robust
academic resources. This project will provide the applicant with a comprehensive training program that
includes personalized mentorship, avenues for presenting research findings, and opportunities for career
development. Through these combined efforts, the applicant will evolve into an independent, proficient
translational researcher who will specialize in biomarker development for diagnostic advancements.

Public health relevance
PROJECT NARRATIVE Cancer is the second leading cause of death, and earlier detection leads to better survival outcomes. While promising, recent advances in plasma DNA blood tests do not yet achieve adequate diagnostic accuracy to be widely useful for early cancer detection. This project seeks to study a ubiquitous, but under-utilized, class of genomic changes in cancer DNA called structural variants to develop an accurate cancer detection blood test based on whole genome sequencing of plasma DNA.